Investigating regeneration factors in the aging mammalian liver

PROJECT SUMMARY
Every human being is endowed with a finite number of neurons that must endure a lifetime of environmental
stressors. This proposal focuses on studying a neuronal stress response and recovery mechanism with
relevance to neuronal function and survival. These studies are directly applicable to human disease, aging, and
external impacts of neuronal health. Briefly, we have found that neuronal cells respond to heat stress in a non-
canonical way, by downregulating translation. This is rapidly recoverable when returned to baseline conditions
within a finite window, beyond which point the cells die. We also discovered that stress response factors were
being activated during recovery and are important for neuronal cell function. Based on these and other original
findings during the predoctoral phase, our central hypothesis is that neurons endure heat stress in part through
translational reprogramming to prepare the system for survival in the event that recovery is an option. Testing
this hypothesis, we discovered neurons upregulate Hsp70 in order to survive this recovery phase. Intriguingly,
upregulation of Hsp70 has been shown to be relevant to a variety of neurodegenerative disorders, including
Alzheimer’s disease. The rationale for the proposed research during the F99 phase is that the molecular
programs that mediate neuronal function and survival during heat stress are poorly understood and further
understanding will provide critical insight into the underlying causes of stressors that impact the human nervous
system in health and disease. Given the critical importance of neuronal stress response to human health, the
long-range objective of the proposed research is to understand the role of dysfunctional stress response in
neurodegeneration and how it contributes to decreased neuronal stress resilience and inability to recover from
stress. We will do this through biochemical, molecular, cellular and physiological measurement to characterize
stress response in neuronal cells and molecular mechanisms essential for recovery. Specifically: Aim 1. To
investigate the mechanism of stress induced translation regulation and recovery, to test our hypothesis
that heat stress induced translation reprogramming is vital to prepare the system for potential recovery and is a
key feature in neuronal health and survival; Aim 2. To study disrupted proteostasis in purkinje neurons of
a cerebellar ataxia mouse model, to test my hypothesis that mutations resulting in the loss of RREB1 alters
protein degradation, which may participate in the observed neurodegeneration and make cells more susceptible
to cellular stress. The completed predoctoral and proposed F99 studies create a rigorous program for studying
neuronal stress response that will be applied to the proposed K00 studies. The proposed K00 studies will identify
factors that lead to more rapid onset or progressive neurodegenerative disease, as well as factors that disallow
neuronal recovery from stress. Findings from the K00 hold promise for generating therapeutic targets to extend
cognitive well-span and promote neuronal recovery from stress.

Public health relevance
NARRATIVE The proposed studies apply biochemical, molecular, cellular, and physiological measurements to study heat stress induced translation reprogramming in primary mouse neuronal cells. Completion of the aims in this proposal will demonstrate which molecular mechanisms are employed and how regulation of these pathways play a role in neuronal heat stress response and recovery for cellular function and survival, with potential relevance to neuronal health and aging. Training and skills acquired in the F99 phase will support transition to aging and AD-relevant research in the K00 phase.